Integrative Metabolomics of Sarcoidosis Diagnosis and Progression

PROJECT SUMMARY/ABSTRACT
Sarcoidosis is a systemic granulomatous disease whose pathogenesis involves both genetic and environmental
factors. Diagnosis of sarcoidosis is difficult and often delayed since there is no confirmatory laboratory test. Many
sarcoidosis patients develop progressive pulmonary disease, which is associated with a higher mortality rate.
However, no reliable biomarkers of diagnosis or prognosis exist to identify patients with disease or at risk of
progression. In addition, significant disparities exist in sarcoidosis outcomes, with race and sex differences in
lung function and mortality, and African American (AA) women having the worst outcomes. Thus, there is a need
for studies focusing on sarcoidosis diagnosis and progression, including a sex and gender-diverse population,
with limited studies focusing on gene expression, in our exciting preliminary sarcoidosis metabolomics data at
National Jewish Health (NJH). We found the arginine availability index (AAI, Arginine/ [Ornithine+Citrulline]) is
lower, and linoleate is higher in sarcoidosis cases vs. controls. We also observed racial and sex differences in
the metabolomic profiles: European American sarcoidosis cases have a much lower AAI than AAs; female
sarcoidosis cases have much higher linoleate levels than males. These findings support the feasibility of using
metabolomics to identify potential blood signatures. Yet, molecular signatures from a single omics type are
generally underpowered and may be biased, given disease complexity. Thus a systems biology investigation
using multi-omics and advanced machine learning algorithms would be useful to identify molecular signatures of
progressive vs. non-progressive pulmonary sarcoidosis. Specifically, this proposal will incorporate single
nucleotide polymorphisms (SNPs) and gene expression with plasma metabolomics/lipidomics to construct and
validate predictive sarcoidosis diagnosis and progression models. We hypothesize that blood arginine and
arginine metabolism pathway-related SNPs and genes are associated with pulmonary sarcoidosis risk and
prognosis, and these blood signatures differ by genetic ancestry and sex. Utilizing pre-existing blood samples at
NJH as a Discovery Cohort, we will validate the results with prospectively collected blood, lung function, and
chest imaging (Validation Cohort) at NJH and Mount Sinai Health System. We proposed the following aims: Aim
1: Determine blood diagnostic signatures associated with pulmonary sarcoidosis vs. healthy controls. Aim 2:
Define baseline blood prognostic signatures of progressive pulmonary sarcoidosis integrating clinical, SNP, gene
expression, and metabolomic/lipidomic data. Aim 3: Identify the longitudinal blood signature
metabolomic/integrative omics dynamics contributing to pulmonary sarcoidosis progression. This will represent
the largest integrative metabolomics study in a diverse sarcoidosis population to date, enabling the identification
of diagnostic (Aim 1) and prognostic (Aim 2) blood signatures with longitudinal assessment (Aim 3). Ultimately,
this study will identify potential candidates for therapeutic targets and biomarkers motivating preventive
approaches for sarcoidosis progression in future studies.

Public health relevance
PROJECT NARRATIVE Diagnosis of sarcoidosis is difficult, and many sarcoidosis patients develop progressive pulmonary disease. We hypothesize that blood arginine and arginine metabolism pathway-related SNPs and genes are associated with pulmonary sarcoidosis risk and prognosis, and these blood signatures differ by genetic ancestry and sex. Ultimately, this study will identify potential candidates for therapeutic targets and biomarkers motivating preventive approaches for sarcoidosis progression in future studies.